Extracellular regulation of Xenopus development

Summary
Cell-cell communication in the early embryo specifies cell fates and orchestrates collective cell
movements. One of the main drivers of collective cell behaviors in vertebrates is the core planar
cell polarity (PCP) pathway. Genetic studies demonstrated the requirement for vertebrate PCP
proteins in many morphogenetic processes including neural tube closure. Our preliminary data
revealed the anteroposterior and the mediolateral axes of PCP in the Xenopus neuroectoderm
that are marked, respectively, by Vangl2 and Diversin protein clusters. The proposed study will
test a hypothesis that the two orthogonal PCP axes are mediated by distinct signaling
pathways. This will be achieved using a combination of cell biological, proteomic and live
imaging approaches in Xenopus, a powerful experimental model allowing rapid functional
analysis in vivo. The medially-enriched PCP clusters will be studied by identifying Diversin-
interacting proteins and correlating the dynamics of their assembly and localization with Myosin
II-dependent cell behaviors in the neural plate and epidermal ectoderm. The regulation of the
anteriorly-enriched PCP clusters and neural tube folding by fibroblast growth factor (FGF)
signaling will be investigated and the relevant structural motifs and intracellular pathways will be
defined. Wild-type Vangl2 will be compared to mutated Vangl2 constructs that are not sensitive
to FGF signaling. The proposed study will reveal the relative contributions of secreted growth
factors and actomyosin contractility to morphogenesis in early vertebrate embryos. These
experiments will expand the knowledge of morphogenetic mechanisms that are critical for
normal development and often disrupted in disease.

Public health relevance
This application focuses on cell-cell communication and signaling needed to polarize and shape the vertebrate embryo. The proposed studies will contribute to the knowledge of molecular mechanisms that operate in normal development and often impaired in congenital defects, ciliopathies and cancers.